STEROL 27 HYDROXYLASE REGULATION VIA C1Q RECEPTORS

Patients with systemic lupus erythematosis have accelerated atherosclerosis due to an unknown mechanism. This proposal hopes to further understand that mechanism by determining the range of sterol 27-hydroxylase mRNA levels in the peripheral blood monocytes of female subjects in three categories: SLE, non-SLE patients treated with high dose steroids, and normals. The lab was used for oligonucleotide synthsis, and BAL.